Immunomyoblasts in muscle regeneration

Abstract
Satellite cells are muscle-resident stem cells responsible for postnatal muscle growth, maintenance and
regeneration. In response to muscle injury, quiescent satellite cells are activated, enter the cell cycle and
proliferate, then differentiate to repair the injury or self-renew to replenish the satellite cell pool. In order for
satellite cells to regenerate injured muscles, the cells have to interact and coordinate with a number of other
resident and infiltrating cells during the regeneration. The cell-cell communication is crucial for efficient
muscle regeneration but how different types cells interact in the regenerating muscle is poorly understood.
We have recently employed single cell RNA sequencing (scRNA-seq) to dissect the various cell populations
and they interactions during muscle regeneration. This scRNA-seq analysis identifies a new subset of
satellite cells with an immune gene signature that allows them to uniquely interact with the immune cells. We
call these cells immunomyoblasts (IMBs). The existence of IMBs in regenerating muscle is also confirmed
by another independent scRNA-seq study and the immune gene signature is confirmed in our preliminary
studies. The discovery of IMBs not only adds a new dimension of heterogeneity to satellite cells but also
opens a new avenue to understand how satellite cells communicate with immune cells to accomplish timely
resolution of inflammation and completion of regeneration. Based on this exciting discovery, the overall goal
of this proposed study is therefore to explore the origin, dynamics and physiological function of IMBs; and
elucidate the regulatory pathways that underlie the function of IMBs. Upon completion of the project, we will
fill an important knowledge gap on the biology of the newly discovered IMBs. Such knowledge will provide an
immediate clear picture underlying the bilateral crosstalk between satellite cells and immune cells. In the
long-run, the knowledge from this work will have important implications in developing novel strategies to
modulate the IMB– immune cell crosstalk to improve the regenerative capacity of damaged or degenerated
muscles in response to acute injury or under degenerative disease conditions.

Public health relevance
Project Narrative Muscle stem cells are required for muscle maintenance and regeneration, especially under disease and aging conditions. This project aims to explore the function and regulation of a novel subset of muscle stem cells that uniquely interact with the immune system to mediate efficient muscle repair. Knowledge from the proposed work will benefit future studies into treatment of degenerative diseases and age-related muscle wasting.